Enhancing Healthcare Delivery and Patient Outcomes: Noninvasive Wireless Sensors to Improve Ventricular Shunt Monitoring, Reduce Imaging, and Alleviate the Burden on Providers, Patients, and Families

ABSTRACT
Hydrocephalus is a common and costly neurological condition caused by cerebrospinal fluid (CSF) buildup in
the ventricles of the brain. It affects >1 million American and occurs in 1-5 of every 1,000 live births worldwide.
While there is no cure for hydrocephalus, it is typically treated via the surgical implantation of a shunt, a
pressure-regulated tube that drains excess CSF away from the ventricles to a distal absorptive site, most often
the peritoneal cavity.
Unfortunately, shunts are highly failure prone, with >50% of shunt recipients requiring surgical revision or
replacement within a decade of implantation. Indeed, surgeries related to hydrocephalus are the most common
neurosurgical procedures performed in children. More challenging, however, is the nature of shunt
malfunctions: early symptoms are clinically non-specific and include headaches, nausea, and fatigue. As a
result, accurately diagnosing shunt malfunction is difficult and regularly leads to unnecessary emergency
department (ED) visits, frequent invasive testing, and a significant mental and physical burden for patients and
their families. Moreover, long-term surveillance of implanted shunts currently requires routine imaging and
creates a significant healthcare cost burden for patients and families.
FlowSense, a flexible, wearable medical device, allows for a non-invasive, radiation-free, reliable, and fast
assessment of CSF flow in under 10 minutes by utilizing the principle of thermal anisotropy. The flow
information gathered by the device aims to be highly clinically useful as an aid to shunt malfunction diagnosis.
The proposed work in this grant follows the successful completion of Phase I (Feasibility, Technical
Development) and Phase II (Regulatory, Clinical Safety and Effectiveness) work. We aim to drive clinical
adoption of FlowSense by improving device manufacturability and establishing clinical utility in both the ED and
outpatient setting with the goal of improving clinical workflow, reducing unnecessary and time-consuming
diagnostic testing, and decreasing the disease burden on patients and families.

Public health relevance
NARRATIVE Hydrocephalus, a common neurological condition caused by cerebrospinal fluid buildup in the ventricles of the brain, is typically treated via the surgical implantation of a shunt, a failure-prone drain that triggers many emergency department visits and requires long-term imaging surveillance creating a significant healthcare burden for patients and families. FlowSense, a flexible, wireless medical device, allows for a non-invasive, radiation-free, reliable, and fast assessment of CSF flow by utilizing the principle of thermal anisotropy. The proposed work in this Phase IIb grant aims to drive clinical adoption of FlowSense by improving device manufacturability and establishing clinical utility in both the ED and outpatient setting with the goal of improving clinical workflow, reducing unnecessary and time-consuming diagnostic testing, and decreasing the disease burden on patients and families.